Development of foundational building blocks for stable genetic modification of sea urchin embryos

PROJECT SUMMARY
Animal models are essential for understanding the mechanisms of development, and for
uncovering the early life origins of disease. The utility of these models depends on the effective
application of genetic methods to establish causal relationships between genes and phenotypes.
The goal of this proposal, targeted to the Office of Research Infrastructure Programs (ORIP), is
to build resources that dramatically improve the reproducibility, utility, and efficiency of research
in sea urchins - which are used by hundreds of researchers across numerous NIH-supported
projects. These resources include modular founder lines (“building blocks”) enabling myriad
approaches, from cell and stage-specific mutagenesis to combinatorial fluorescent reporter
expression, to active genetics. The Aims of this proposal utilize both traditional (transposon-
mediated transgenesis) and modern (CRISPR/Cas9) techniques to meet these diverse needs.
Further innovation of the work comes from application of this modular genetic design to a species
with the ideal biological features and background of knowledge for transgenesis and research-
scale culturing. This work will have transformative impact on research across the mandates of
NIH, including studies on reproduction, membrane transport, and gene regulation.

Public health relevance
PROJECT NARRATIVE Many human diseases and malformations are caused by disruption of the early stages of life. Animal model organisms are essential for studying how these early stages work, and for understanding how diverse environmental agents – from toxic chemicals to pathogens – affect health. Here we will develop transformative new tools to enable rapid genetic manipulation of a classical developmental animal model, used widely to understand these relationships between development and disease. The resulting resource will dramatically accelerate the tempo and impact of more than 20 current NIH sponsored projects using this research organism.